Sleeping well in a changing climate: The effects of rising temperatures and extreme weather events on sleep and other aspects of health in rural Appalachia

Insufficient sleep (habitual sleep duration of ≤6 hours) is a costly public health problem that is more prevalent
among health disparity populations (e.g., racial minorities, adults of low socioeconomic status). Climate change
and climate-sensitive disasters demonstrate a detrimental impact on sleep and associated downstream health
outcomes. Increasing temperatures are linked to diminished sleep time and quality, and negative impacts are
heightened among populations with fewer economic resources. Extreme weather events due to climate change
often result in displacement, trauma, and economic instability; these stressors directly impair sleep. The fast-
growing burden of climate-related disaster recovery disproportionately disadvantages populations with existing
health disparities. These data hold direct relevance to our parent R01: Researching Equitable Sleep Time in
Appalachia (REST-KY; MD016236). REST-KY focuses on rural Appalachian adults, whose serious health
inequities include multiple health morbidities, premature mortality, and high rates of insufficient sleep. While
our project was designed to evaluate mechanisms contributing to pre-existing regional sleep and health
deficiencies over a two-year period, Appalachian Kentucky’s July 2022 climate-change-related catastrophic
flood event has led us to broaden the scope of our research. We will recruit a cohort of 400 adults from 6
insufficient sleep “hotspot” counties (n=200) in Appalachian KY (where 25-58% of adults report insufficient
sleep 15+ nights/month), and 6 similarly rural and economically distressed non-“hotspot” counties. Five of the
12 counties suffered widespread flood damage. The use of a mixed method, longitudinal burst design in the
parent R01 will allow us to evaluate mechanisms contributing to both sleep deficiencies and health over two
years in this rural community. The present supplement is responsive to the NOT-HD-23-006 NOSI and
addresses three of the four core pillars of the NIH Climate Change and Health Initiative (Health Effects
Research, Health Equity, and Training and Capacity Building) by expanding our trans-disciplinary team to bring
together climate and health scientists. The proposed activities are fully within the scope of the aims of the
parent R01: a) collect objective measurements of outdoor and indoor temperature, humidity, and barometric
pressure as additional predictors of objective sleep health; b) add quantitative measures of beliefs about
climate change and health to examine associations with sleep and other health outcomes; and c) add
quantitative measures and conduct supplemental qualitative interviews with flood survivors in the parent R01
cohort to evaluate perceptions of factors contributing to the flood disaster (including climate change), how the
flood impacted their sleep and health, and long-term recovery resources and needs. Our findings will offer
unprecedented insight into the intersections of climate change, sleep and health in an understudied rural health
disparity population. Results will inform strategies to increase health equity in the face of a rapidly changing
climate, and thus will have strong potential for public health impact.

Public health relevance
We know that rural residents in the Appalachian region of the Southeastern United States have the nation’s highest rates of insufficient sleep (habitual sleep duration ≤6 hours), but the reasons for this are unclear. This issue is particularly concerning, as these same rural residents also face substantially higher than average rates of negative health outcomes including heart disease, cancer, diabetes, obesity, depression, and substance use disorders. We will follow a group of Appalachian adults over the course of two years to track their sleep, physical and mental well-being, and health behavior (e.g., substance use, smoking, diet, exercise), in order to better understand the culturally relevant factors that predict difficulties with both sleep and health in this unique and underserved, rural population.